Validation of an in vitro model of progressive fibrosis that mimics Idiopathic Pulmonary Fibrosis

Abstract
We have developed a 3D bioengineered human induced pluripotent stem cell (iPSC) derived model of IPF that
displays progressive fibrosis and closely phenocopies several characteristics associated with IPF. This model is
an extension of our 2D model of progressive fibrosis (Vijayaraj et al., Cell Reports – in press). To make our
progressive fibrosis model specific to IPF, we have developed it into a model system that utilizes the lung 3D
architecture and specific cell types. Our 3D model displays additional features of IPF such as airway epithelial
cell (AEC) apoptosis, epithelial-mesenchymal transition (EMT) and replacement of alveolar architecture.
Our proposal aims to improve and validate this 3D model such that it will be amenable to a high throughput drug
discovery platform in a patient specific manner for precision medicine. Our project aims to use our unique
stem/progenitor cell models of IPF to increase our understanding of the disease and for drug discovery.
Specific Aim 1. To improve and validate the 3D bioengineered human iPSC derived model of IPF
A. To validate the 3D model of IPF by performing extensive characterization of the model compared to human
IPF lung tissue.
B. To characterize the heterogeneity of IPF seen across different patients.
C. To characterize the 3D IPF model by known genetic risk factors.
Specific Aim 2 – To use our 3D bioengineered iPSC-derived model to study cellular plasticity in IPF
To profile cellular plasticity of AECs in our 3D model of IPF and compare it to human IPF tissue using single cell
RNA sequencing.
Specific Aim 3 – To develop and standardize a high throughput drug screening (HTS) platform to identify
new anti-fibrotic therapies using the 3D model of IPF
A. To develop a HTS using the 3D model of IPF.
B. To develop robust, image analysis pipelines that employ a combination of advanced deep learning
techniques and traditional image processing methods to generate quantitative measures of tissue health.
C. To develop and run a pilot HTS to identify small molecules that will perform one or more of the following a)
prevent apoptosis of AEC; b) enhance apoptosis of mesenchymal cells; c) decrease expression of -SMA.
Our team includes international experts who study lung biology (Gomperts, UCLA), biology of fibrosis (Vijayaraj,
UCLA), an IPF clinician and researcher (Belperio, UCLA), lung pathologist (Wallace, USC), iPSC airway
epithelial cell differentiation (Spence, Michigan), single cell RNA seq and analysis (Plath, UCLA), and high
throughput drug discovery (Damoiseaux, UCLA) with machine learning algorithms for analysis (Shattuck, UCLA).
We are a highly collaborative team that is working together using innovative, patient relevant research
approaches to tackle the challenges of modeling IPF to identify new therapies.

Public health relevance
Project Narrative We have developed a 3D bioengineered model of human Idiopathic Pulmonary Fibrosis. We aim to further develop, improve and validate this model as a clinically relevant model for Idiopathic Pulmonary Fibrosis. The overall goal is to develop this model for drug screening to find new therapies for this terrible lung disease.